Perinuclear Ryanodine Receptors and Cardiac Remodeling

The development of pathological cardiac hypertrophy requires the stimulation of gene transcription activated by
Ca2+-dependent signaling pathways. However, targeting specifically these Ca2+-dependent pathways is difficult
due to the multiple functions of Ca2+ in myocyte physiology. Recent evidence suggests that formation of distinct
Ca2+ microdomains provide the molecular mechanism that allows for specificity in Ca2+ signaling. Therefore,
understanding the components and regulation of each microdomain is key for the development of novel
therapeutics for the prevention and treatment of pathological hypertrophy. We have previously demonstrated
that binding of the Ca2+/calmodulin-dependent protein phosphatase calcineurin (CaN) to the muscle-specific A
Kinase Anchoring Protein mAKAPβ mediates the induction of myocyte hypertrophy. New data show that the
mAKAPβ signalosome is also required for a perinuclear Ca2+ transient required for the activation of transcription
factors responsible for myocyte hypertrophy. We hypothesize that a pool of perinuclear RyR2 localized to the
mAKAPβ signalosome is responsible for this Ca2+ microdomain, and importantly, that these perinuclear RyR2
are segregated from those involved in excitation-contraction coupling (E-C coupling). The central hypothesis of
this proposal is that RyR2 localized to mAKAPb signalosomes induces perinuclear Ca2+ transients required for
CaN-dependent gene expression that are independent of the canonical function of RyR2 in E-C coupling. Aim 1:
Perinuclear RyR2 associated with mAKAPβ signalosomes are within an independent Ca2+ signaling
compartment that regulates myocyte hypertrophy. The goal of Aim 1 is to demonstrate that mAKAPb-
signalosome associated RyR2 is responsible for bAR-stimulated perinuclear Ca2+ transients that induce myocyte
hypertrophy and that this pool of RyR2 is regulated independently from RyR2 involved in E-C coupling. Using
novel, targeted activators and inhibitors of the perinuclear RyR2, we will demonstrate the importance of
perinuclear RyR2 for the regulation of pathological gene transcription, and show that modulation of perinuclear
RyR2 does not impact contractility. Furthermore, the importance of PKA-mediated phosphorylation of RyR2 at
several sites will be investigated. Aim 2: The dimensions of the mAKAPβ Ca2+/CaN compartment. Aim 2 will
map the perinuclear Ca2+ domain that is specified by the mAKAPb signalosome and demonstrate that this
perinuclear compartment does not affect cytosolic CaN activity, but functions to maintain perinuclear CaN
activity. Aim 3: Requirement of perinuclear RyR2 signaling for pathological remodeling in vivo. The therapeutic
potential of targeting perinuclear RyR2 in mouse models of cardiac hypertrophy will be investigated in Aim 3.
Through these Aims, this proposal will define a novel signaling compartment orchestrated by mAKAPb that is
required for pathological gene transcription and induction of cardiac disease, but does not affect E-C coupling.
Furthermore, completion of this project will reveal how targeting mAKAPb signalosomes can be therapeutically
beneficial in the prevention of cardiac remodeling and heart failure.

Public health relevance
Heart failure is a syndrome of major public health significance. An estimated 6.2 million Americans are currently suffering from heart failure, and this number is estimated to increase 46% by 2030. A better understanding of the molecular mechanism underlying cardiac remodeling, including pathological myocyte hypertrophy, should significantly help in the design of new therapeutics for treatment, thereby decreasing patient mortality.